LIVE IMAGING OF CRANIAL NEURAL CREST CELLS IN THE ZEBRAFISH EMBRYO

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Describe the behavior of cranial neural crest cells in live zebrafish embryos in order to better understand how cell behavior influences morphogenetic events and how changes in this behavior may result in craniofacial malformations.